Contact-dependent determinants of human natural killer cell development

Abstract:
Human natural killer (NK) cells are traditionally identified as CD56+CD3- large granular innate lymphocyte that
can detect and eliminate virally infected and malignant cells. Although CD56 is used to identify NK cells, its
function is not fully understood. CD56 or neural cell adhesion molecule (NCAM) was first described in neural
progenitor cells where it can engage in homotypic and heterophilic interactions with its ligands (e.g., NCAM,
fibronectin domains, sulfate proteoglycans) and regulates neuron survival, migration, and development.
Interestingly, both xenogenic murine developmentally supportive stroma (e.g., EL08.1D2 and OP9) commonly
used for in vitro NK cell differentiation from CD34+ progenitors and stromal cells in sites of hematopoiesis (e.g.,
bone marrow MSC) express NCAM when compared non-developmentally supportive stroma. Furthermore,
work published in the Mace Lab has revealed that inhibition of CD56 (NCAM) mediated interactions between
NK cells and stromal cells by a blocking antibody perturbs in vitro NK cell development resulting in decreased
NK cell number and migration. I hypothesize that Ncam on developmentally supportive stromal cells and
CD56 on NK cells mediate interactions between stromal cells and NK cells that are required for NK cell
development, survival and proliferation. My first aim is to characterize the functional role of Ncam
expression on developmentally supportive stroma. My preliminary data suggests that the use of Ncam1
knockout murine EL08.1D2 stromal cells for in vitro NK cell differentiation leads to decreased NK cell
developmental intermediate survival, proliferation, and migration. I will determine whether Ncam, on
developmentally supportive stroma, mediates their ability to support NK cell development, survival, and
migration. My second aim is to define the requirement of CD56 on human NK cells for their development and
migration. Work by the Mace lab has shown that inhibition of CD56 on NK cells, via blocking antibody, leads to
a decrease in cell migration and dysregulation of the actin cytoskeleton. I will delete CD56 in human NK cell
progenitors and follow their development in vitro by transcriptomic and phenotypic analysis. Together our
study will bring light to a previously unknown CD56 mediated interactions and signaling pathways
required for human NK cell proliferation, survival and migration through development.

Public health relevance
Narrative: CD56 (NCAM) is a commonly used marker for human natural killer (NK) cells, however its role in NK cell function and development is poorly understood. Our study will bring light to a previously undocumented NK cell developmental requirement of CD56-mediated homotypic and heterophilic interactions with stromal cells. Understanding the role of CD56-mediated interactions in NK cell function and maturation is important for improving therapeutic approaches and understanding how lymphocyte interactions with their microenvironment shape their development.